Administrative Core

ADMINISTRATIVE CORE (ADM): PROJECT SUMMARY
The Administrative Core (ADM) is a necessary component of the Columbia University Senescence Tissue
Mapping (CUSTMAP) Center; it will provide research and logistical oversight and facilitate communication
amongst all Center Cores as well as with the SenNet Consortium Organization and Data Coordination Center
(CODCC), the SenNet consortium at large, and the NIH. The ADM, composed of a Director, all Center PIs (MPIs),
an Executive Committee (all Core leadership), and support staff (Program Manager and Systems Analyst), will
oversee and coordinate the direction of three Cores (a Biospecimen Core (BIO), a Biological Analysis Core
(BAC), and a Data Analysis Core (DAC)). These Cores will contribute to the study of senescence in three primary
tissue types, i.e., skin, brain, and spinal cord, across the adult lifespan. The ADM will have three main functions
in support of the CUSTMAP Center and ultimately the SenNet consortium initiative. The first is Leadership,
highlighted in Aim 1: Provide scientific leadership and governance structure to ensure integration and
function of the CUSTMAP Center components and activities. CUSTMAP Center activities will span multiple
sites (CUIMC-All Cores, Edinburgh University-BIO, New York Genome Center-BAC, and New York University-
DAC) and therefore will require a central governing and organizing structure. The ADM will be the hub for
decision making, all Center documentation, and adherence to ethical policies. Importantly, the ADM will ensure
the CUSTMAP Center research is compliant with agreed upon standards and a resource sharing plan, formally
set by the Center and with the NIH. The second role is Center Coordination, highlighted in Aim 2: Facilitate
internal communication and promote synergy within the CUSTMAP Center. The ADM will provide
coordination across all CUSTMAP Center Cores. Central to this Aim is an innovative, customized laboratory
information management system (LIMS) in coordination with OpenSpecimen to track samples, the associated
metadata, and experimental outputs. The ADM will organize regular Executive Committee meetings as an open
forum for the sharing of successes, ideas and trouble shooting. The ADM will compile biannual Progress reports
from each Core for evaluation by the SenNet Steering Committee and annual reports for evaluation by an Internal
Advisory Board (internal to CUIMC, external to CUSTMAP). Finally, the ADM will facilitate Network
Coordination, highlighted in Aim 3: Foster collaboration and integration of the CUSTMAP Center with the
SenNet consortium. The ADM will collaborate with the CUSTMAP DAC and the SenNet CODCC to develop
harmonious Standard Operating Practices (SOPs), Common Data Elements (CDEs) and suitable data packages
and will oversee the delivery of quality data to the CODCC. The ADM will also leverage interactions with other
TMCs in the SenNet consortium to optimize SOPs, assay protocols, consent materials, and data analysis, etc.
The ADM will provide the seamless integration of multiple moving parts, at multiple sites, to produce high quality,
meaningful data towards the SenNet goal of high-resolution atlases of senescence in diverse healthy tissues.